Unobtrusive measurement of sleep disordered breathing in the home

DESCRIPTION (provided by applicant): The long-term goal of our project is to develop tools that can be used to diagnose and assess sleep disorders unobtrusively in a patient's home. Sleep disorders and sleep deprivation are significant public health problems. The U.S. Institute of Medicine estimates that 70 million Americans suffer from chronic, treatable sleep disorders. One of the most common and problematic sleep disorders is obstructive sleep apnea (OSA), where a partial collapse or obstruction of the pharyngeal airway results in intermittent reduction in blood oxygen saturation and disruption of sleep. The traditional gold standard for diagnosing and monitoring these disorders is overnight polysomnography (PSG). Unfortunately PSG is an expensive, obtrusive, and inconvenient test in which multiple sensors are attached to patients who are already struggling with sleep. A simpler tool used to screen for sleep disordered breathing (SDB) in a patient's home over multiple nights would help clinicians decide if PSG is indicated, providing a much needed and currently unavailable window into a patient's apnea status over multiple nights in their natural sleep environment. In this study, we will continue ou efforts to understand how load cells could be used for this purpose. We have used load cells under the supports of the bed to quantify the frequency and severity of apneas and hypopneas. We now seek to understand how this system could be simplified and used effectively in a home setting. Our Specific Aims are: (1) to develop improved algorithms to detect lying position on the bed during load cell collection~ (2) develop algorithms to separate the breathing and movement signals from two individuals sharing a bed~ and (3) to determine the most effective minimal configuration of load cells (number, location, and loading) that can be used to accurately measure the severity of sleep apnea.

Public health relevance
PUBLIC HEALTH RELEVANCE: Estimates of the prevalence of sleep disorders in the US range from 50 to 70 million people, and as many as 9% of middle-aged American men suffer from sleep disordered breathing. The direct cost of treating sleep disorders has been estimated in the range of $30-50 billion per year~ indirect costs including absenteeism from work and fatigue-related accidents are estimated to be $210 billion. The proposed study would create a tool allowing unobtrusive in-home assessment of sleep-disordered breathing, for screening patients and following treatment.